Cancer Genetics of Long Telomere Syndromes

Abstract
This application focuses on understanding the genetic basis of a recently recognized cancer-prone syndrome
caused by long telomere length. It is driven by extended cellular longevity, a mechanism that is distinct from
tumor suppressor- and oncogene-mediated familial cancer syndromes. Telomere length is constrained in the
human population to a relatively narrow range and telomerase elongation is tightly regulated. Recent studies,
from multiple lines of evidence from our group and others, have uncovered that genetically-determined short
telomere length, at certain thresholds, is protective against most age-related malignancies. Exceptions include
squamous cancers that arise in the setting of T cell immune exhaustion, and myelodysplastic syndrome and
acute myeloid leukemia that arise in the setting of hematopoietic stem cell failure. These cancers occur at
significantly higher rates among individuals with Mendelian short telomere syndromes. The relatively lower risk
of other age-related malignancies in the short telomere syndromes has deep mechanistic underpinnings as
short telomere length mediates cellular senescence and apoptosis, thus limiting cancer evolution in nearly all
tumor-prone animal models. By contrast, there is emerging evidence that long telomere length is associated
with significantly increased cancer risk in the human population with common variants in telomere genes
increasing the risk for more than 28 malignancies. Our group recently reported on an autosomal dominant long
telomere syndrome caused by heterozygous mutations in POT1. Haploinsufficiency of POT1 enhances
telomerase elongation in vitro, and we found mediates ultra-long telomere length. POT1 mutation carriers with
long telomeres had high cancer penetrance, near 100% by age 60, and were prone to multiple malignancies
including melanoma, thyroid cancer, sarcoma, epithelial and hematologic malignancies. Alongside, they shared
a predilection to high rates of clonal hematopoiesis, which we phylogenetically inferred arose in the first
decade of life and was sustained by the longer telomere length. In more recent work, we found two other
mutant telomere genes phenocopy the long telomere syndrome phenotype supporting wide locus
heterogeneity. This application aims to advance this new and timely area. We will identify additional novel
mechanisms for the long telomere syndrome with the goal of identifying high risk groups who would benefit
from screening and surveillance. The proposed studies will define the role of these variants in familial cancer
predisposition, and examine how they disrupt normal telomere length regulation in relevant genetic models and
in human cancer-prone families. Building on our recently published data, and leveraging unique resources in
our group, we will also examine how the long telomere background influences cancer somatic landscapes. The
proposed application promises to identify novel large effect size cancer-predisposing variants in children and
adults and define their underlying mechanisms of pathogenicity in relevant models, while establishing
approaches that will advance patient care through early detection and prevention protocols.

Public health relevance
Project Narrative Understanding the genetic basis of cancer provides opportunities for its early detection, prevention and tailored treatments. We recently described a common, heritable cancer-prone syndrome that affects children and adults; it is driven by inherited predisposition to long telomere length and extended cellular lifespan. This application identifies novel risk factors that predispose to the long telomere cancer-prone state and probes the tumor landscape with the goal of identifying biomarkers that can used for early detection and prevention.